Regenerative Sciences Training Program(RMI)

This proposal seeks support for the development of a new interdisciplinary training program in Regenerative Science. Repair or regeneration of tissues can be characterized as a symphony of cellular activities often beginning with an acute inflammatory response followed by granulation tissue infiltration, recruitment, proliferation and differentiation of progenitor cells, matrix formation and organization, and eventual remodeling. The process occurs within the context of biologic and mechanical signals. While many scientists, engineers and clinicians working across numerous disciplines are dedicated to advancing the repair or regeneration of tissues and organs, they fall short in their ability to communicate, interpret, or integrate across the many core competencies that we believe are required to make substantial advances in regenerative medicine. These core competencies include: developmental biology, extracellular matrix structure and organization, bioregulatory signaling, tissue structure and function, preclinical models development, structural and computational modeling, clinical research design principles, and commercialization and regulatory parameters. This program will admit biologists, engineers and clinicians with training depth in one or more disciplines and augment their abilities by teaching them critical aspects of these core competencies through didactic and research intensive experiences. While this training program will expand to train in all organ or tissue systems in the future, its initial training will focus on musculoskeletal tissues.